Redefining Dental Imaging: Low-Cost MRI with Relaxed Field Requirements

The goal of this research is to test the feasibility of using a specialized pulse sequence,
MB-SWIFT, and an intraoral coil to detect the dentinoenamel junction (DEJ) (an important
landmark for treatment decisions in dentistry) in teeth at an affordable, lower field strength
(0.7T) with greater inhomogeneity than conventional MRI systems. This grant also seeks
to affirm siting requirements for an MRI system dedicated for dentistry. This would allow
development of an MRI system for dentistry that is cost-effective and able to be sited
within conventional dental practices without the need for significant renovations.
The project has 4 specific aims. The first 2 are related to integrating the intraoral dental
coils into an existing 0.7T system and implementing MB-SWIFT on a novel spectrometer.
The 3rd aim seeks to explore how well the system captures the DEJ, and the 4th aim seeks
to definitively validate siting requirements for future MRI systems in dentistry.
If proven to be successful, this technology could help usher in a new era of dental
imaging that is both non-ionizing and allows for greater sensitivity, therefore earlier
detection, of dental diseases. This project supports NIDCR’s strategic priority to,
“Advance discoveries across the translational research spectrum and drive innovations
that improve early diagnosis, prevention, and treatment of DOC diseases...”

Public health relevance
The goal of this project is to validate MRI siting requirements and to test the ability for two novel technologies, a specialized pulse sequence for MRI called MB-SWIFT and a specialized intraoral radiofrequency coil, to be used together to detect key features found in teeth. We will be testing these components in an environment that, if successful, would allow for a less expensive MRI machine to be built and allow wider access of this technology for dentistry. If successful, this technology could help usher in a new era of dental imaging that is both non-ionizing and allows for earlier detection of oral disease.